GBPs in inflammasome activation and host defense to infection

PROJECT SUMMARY/ABSTRACT
Inflammasomes alert the mammalian immune system to the presence of infection and tissue damage. These
cytosolic protein complexes detect danger signals or microbial products released by a wide variety of intracellular
pathogens. In the case of bacterial pathogens, a number of prokaryotic signatures are recognized including the
major cell-wall constituent of most Gram-negative species, lipopolysaccharide (LPS). Detection of LPS inside
host cells activates a “non-canonical“ inflammasome pathway where caspase-4 (formerly caspase-11 in mice)
act as upstream sensors to stimulate inflammasome complex assembly and processing of the pore-forming
protein, Gasdermin D (Gsdmd), further downstream. Gsdmd pores release protective cytokines and contribute
to a lytic form of cell death termed pyroptosis that may help eliminated infected host cells. How these sequential
events are co-ordinated and the host factors involved remains a major question in the field of innate immunity
and host defense. Here, we focus on members of a new 65-73kDa immune GTPase family termed Guanylate-
Binding Proteins (GBPs) that control distinct steps in the non-canonical pathway. Our recent published and
unpublished results suggest specific GBPs target cytosolic bacteria to help liberate LPS for caspase-4 detection
whereas other GBP family members control Gsdmd trafficking to the plasma membrane further downstream and
facilitate bacterial killing. Thus GBPs offer a unique opportunity to dissect how this process unfolds. In Aim 1, we
will test the respective contributions of 4 human GBPs (GBPs1-4) and their closest mouse GBP orthologs
(Gbps1-3) to caspase-4-dependent immunity against Gram-negative Salmonella typhimurium (Stm) infection in
vitro and in vivo. CRISPR-Cas9 deleted human and mouse cells as well as newly-created Gbp1-/-, Gbp2-/-, Gbp3-
/- and tissue-specific Gbp∆chr.3H1 mice will be infected with Stm variants designed to interfere with the recruitment
of GBPs onto the bacterial surface, their responsiveness to LPS, or their ability to facilitate apolipoprotein L
(APOL)-dependent bacteriolysis. Thereafter, we will dissect the molecular and structural mechanisms enlisted
by these GBPs to confer their intracellular functions as part of Aim 2. Here gene-deficient macrophages and
epithelia will be complemented with GBP mutants harboring distinct biochemical lesions to reveal how GBPs
direct the inflammasome core machinery to LPS-positive bacteria for controlling downstream events such as
Gsdmd trafficking to the plasma membrane or APOL-mediated bacterial killing. Native cryo-electron tomography
studies will also examine the GBP defense complex on the bacterial outer membrane that serves as a platform
for inflammasome assembly. Collectively, our proposal examines a new set of host factors that act at different
stages within the non-canonical signaling cascade as part of a unique functional hierarchy, helping choreograph
these events with major implications for the treatment of sepsis and Gram-negative bacterial infections.

Public health relevance
PROJECT NARRATIVE. Inflammasomes are protein assemblies inside host cells that detect the presence of microbial pathogens including Gram-negative bacteria to alert the immune response. This proposal focuses on a new group of host immune proteins - the Guanylate Binding Proteins (GBPs) – that tailor the “non-canonical” inflammasome response specifically against Gram-negative bacteria such as Salmonella that are a major cause of food-borne gastroenteritis and blood-borne sepsis in U.S. intensive care units. Our efforts will uncover how GBPs control the “non-canonical” inflammasome that provides a conceptual framework for therapies aimed at treating life- threatening Gram-negative infections and sepsis.